Developing experimental paradigms for inhalation toxicology to evaluate cardiovascular outcomes and further development in vitro inhalation exposure

The first part of this project conducted for the Division of Translational Toxicology (DTT) is designed to evaluate the use of physiological monitoring parameters (blood pressure, heart rate, heart rate variability, ecg etc.) in routine inhalation toxicology assessments. These parameters are easy translatable to humans, as passive metrics collected and use for human health on a routine basis. These parameters may also offer early indicators of an animal developing a toxic outcome from exposure to a chemical that could be detected before the animal is euthanized, and could allow early intervention for laboratory animal medicine. Telemetry-implanted animals were exposed to a test article in whole-body inhalation chambers for 4 weeks to determine if physiological monitoring parameters would be more sensitive or would be earlier indicators of toxicity when compared to apical outcomes (e.g. histopathology) for known toxic effects of the test article. The second part of this project is for the DTT to continue to optimize use of the government owned Vitrocell 48 2.0 plus exposure system to provide the program with in vitro capabilities that mimic inhalation exposure.